Fostering Cervical Cancer Screening Promotion for Latinx Trans Men Among Medical Students

ABSTRACT | PILOT RESEARCH PROJECT
Transmen (TM) and non-binary individuals (NB; individuals assigned female sex at birth who identify as a man,
male, or another diverse non-binary gender identity on the masculine spectrum) are at higher risk of screening-
detectable cancers. The incidence of cervical cancer among Latinx (a gender-neutral term designating
Hispanics/Latinos (H/L)) is the highest among all ethnic groups in the US. Thus, Latinx TM and NB (LTM-NB)
are at a higher risk for cervical cancer as they lie at the intersection (i.e., gender and ethnic minorities) of two
populations that experience health disparities for this disease. Individual and interpersonal level factors in
interactions with health care providers such as the gendered nature of testing, “misgendering” or use of incorrect
pronouns, and avoidance to discuss issues about body parts associated with their assigned at birth gender have
been identified as some of the key aspects driving cervical cancer disparities among LTM-NB. In addition,
healthcare providers’ negative attitudes and insensitivity can contribute to emotional discomfort for testing,
adding another screening barrier. Our previous studies among LTM-NB in Puerto Rico and Florida show that
providers lack knowledge about specific healthcare needs, have negative stigmatizing attitudes, and manifest
discriminatory behaviors in clinical interactions with LTM-NB. However, although there are existing guidelines to
foster cancer early detection and prevention among TM, no guidelines or interventions address the increased
disparities encountered by ethnic minority LTM-NB. We developed a brief online intervention to improve medical
students’ competencies for cervical cancer education and screening promotion among LTM- NB. The efficacy of
this intervention has already been tested and exhibited medium to large effect sizes. The Aims of this proposed
study are: Aim 1) Test the effectiveness of the intervention in increasing medical students’ knowledge, attitudes,
and skills for providing healthcare to LTM-NB. This will be achieved by conducting a randomized controlled trial
with participants from Ponce Health Science University and from Moffitt Cancer Center-University of South
Florida. Quantitative measures (knowledge and attitudes) and SPS direct observations (behaviors) will be
collected to examine the intervention’s effectiveness. The rationale for this aim is to determine the additional
effect of the measure. Aim 2) Determine the acceptability, appropriateness, and feasibility of implementing the
interventions in real-world medical educational settings. We will implement quantitative self-report measures and
individual interviews with a sub-sample of participants from the experimental condition (n=10) to examine
implementation outcomes (acceptability, appropriateness, and feasibility). The impact of this study will reveal
new effective interventions and implementation strategies. The translational implications of this work will result
in providing medical schools with a cross-cultural tool to train students on cervical cancer prevention for LTM-
NB.